National Health and Nutrition Examination Survey 2019-20201 Nutrition Questionnaire Component for survey participants aged 0 up to 24 Months

Support to the National Center for Health Statistics (NCHS), for the Nutrition Questionnaire Component for survey participants aged 0 up to 24 Months in the National Health and Nutrition Examination Survey (NHANES) and for cognitive testing of the questions prior to fielding. The cognitive testing process begins in 2017 and continues into 2018. This project is a collaborative effort and includes collaboration with CDC/NCHS, DHHS/OASH/ODPHP, NIH/NIEHS-OBSSR-NICHD-ODS-ODP-NCI, USDA/FNS-ERS, and FDA.